Skyline Targeted Proteomics Environment

DESCRIPTION (provided by applicant): With the maturation of proteomics technologies, these tools are being used to improve our understanding of many basic and clinical questions in human and model organism biology - with the ultimate goal of an improved workflow for biomarker candidate validation. To handle this, laboratories have shown that targeted mass spectrometry measurements offer a promising alternative to immunological based assays. Critical to these experiments is software to handle the generation of instrument methods and the consequent analysis of the resulting data. We have developed a client software tool to handle these analyses called Skyline. In the last 2-3 years, Skyline has become one of the most widely software tools in proteomics. In this grant, we propose to continue the development and maintenance of Skyline, which currently supports hundreds of investigators in their basic science, pre-clinical, and translational research. Specifically, our proposal has five aims. 1) Add support for complex experiment models within Skyline's data structure and graphical user interface. 2) Support calibration curves, complex isotopomer deconvolution, routine statistical analyses within Skyline, and new algorithmic developments by the community within the Skyline architecture. 3) Support the analysis of full scan MS1 and MS/MS data. 4) Support targeted proteomics libraries and implement a repository to store and disseminate targeted proteomics methods. 5) Support automatic method optimization and real-time automatic acquisition parameter updates on ThermoFisher triple quadrupole mass spectrometers. PUBLIC HEALTH RELEVANCE: Mass spectrometry has been a fundamental technology for the analysis of proteins in health and disease. Laboratories have shown that targeted mass spectrometry measurements offer a promising alternative to immunological based assays that are the standard for quantitative protein measurements in clinical laboratories as well as basic research laboratories. Critical to these experiments is software to handle the generation of instrument methods and the consequent analysis of the resulting data so our software Skyline is a critical component to making targeted proteomics routine.

Public health relevance
Mass spectrometry has been a fundamental technology for the analysis of proteins in health and disease. Laboratories have shown that targeted mass spectrometry measurements offer a promising alternative to immunological based assays that are the standard for quantitative protein measurements in clinical laboratories as well as basic research laboratories. Critical to these experiments is software to handle the generation of instrument methods and the consequent analysis of the resulting data so our software Skyline is a critical component to making targeted proteomics routine.